CDC-NCHS-NHANES Audiometry Component

This interagency collaborative project will provide support to the National Center for Health Statistics (NCHS), CDC for implementation of nationally representative hearing health examinations and interview epidemiological survey questions for assessment of hearing thresholds and risk factors for hearing loss and related conditions such as hyperacusis and tinnitus in both children and adults.

A special emphasis of the NHANES 2025-2026 epidemiological hearing examination and questionnaire component will be collection of data to assist in studies of hearing loss induced by noise, other ototraumatic, or ototoxic agents. In addition to exposure to noise from personal audio devices, many individuals are exposed to potentially hazardous levels of sound from noisy activities, such as concerts, music venues including bars or dance clubs, sporting events, motorcycles, recreational vehicles, mass transit systems, fireworks, and hunting or target shooting. An estimated 22 million U.S. workers are exposed each year to potentially hazardous noise on the job. As many as 26 million U.S. adults have developed a hearing loss as the result of their noise exposure—hearing losses that are nearly all preventable. This NHANES study also includes blood laboratory assays that will allow research investigators to examine chemical exposure to lead, solvents, and carbon monoxide (e.g., cigarette smoking) effects that cause damage to the ear. These data will also be available as a comparison dataset in future studies of hearing loss, and as a baseline to monitor progress in prevention.

The current protocol for the hearing examination component was developed by NCHS in collaboration with the National Institute on Deafness and Other Communication Disorders (NIDCD) and the National Institute for Occupational Safety and Health (NIOSH).

The target group for the audiometry exam are Survey Participants (SPs) 12–44 years old. The component includes four parts:
1) Questionnaire items. Hearing-related questions are included in the household questionnaire and in the Mobile Examination Center (MEC) pre-exam questionnaire. Questionnaire items collect information on self-reported hearing ability; use of hearing aids and hearing protective devices; relevant medical history; noise exposure history; and conditions that could affect the results of audiometric testing.
2) Otoscopy. A cursory physical examination is conducted of the outer ear. A photo of the SP’s eardrum in each ear is captured with a digital otoscope and sent to NIOSH for interpretation.
3) Tympanometry. An objective evaluation of middle ear function is conducted based on the movement of the eardrum as pressure is varied in the ear canal.
4) Pure tone air conduction audiometry (Hearing Test). A basic evaluation of hearing sensitivity is performed. Hearing thresholds are obtained at seven frequencies (500, 1,000, 2,000, 3,000, 4,000, 6,000, and 8,000 Hz) bilaterally, with a repeat threshold at 1,000 Hz in each ear to verify response consistency. The test is conducted automatically by an audiometer in a quiet space using boothless audiometry. Background noise in the test area is monitored continuously during pure tone audiometry testing. The measured noise levels are linked to each threshold. Thresholds that may have been contaminated by excessive background noise will be flagged in the dataset.

Public health relevance
Hearing is important. Good hearing ability is an essential aspect of normal communication and plays an important role in safety and awareness in nearly every part of daily life. Hearing trouble results in a myriad of difficulties, including communication trouble, difficulty at school or work, social isolation and/or stigmatization, potentially accelerated cognitive decline, and economic ramifications at the family, community, and national level. Adults with hearing impairment are at risk for decreased quality of life, poorer health status, and diminished health care services received. Targeted interventions delivered in a community or medical setting, provided by audiologists, Ear, Nose, and Throat (ENT) doctors [aka, Otolaryngologists-Head and Neck surgeons], neuro-otologists, occupational and physical therapists, pediatricians, gerontologists, and other trained health care workers can potentially mitigate risks for long-term disability. Hearing loss is a widespread problem. It is the third most common chronic physical condition in the United States and is twice as prevalent as diabetes or cancer. Recent statistics indicate that 37.5 million U.S. adults aged 18 and older have some degree of hearing impairment. Approximately 50 million Americans report tinnitus (ringing in the ears), a condition that can be as disabling as hearing loss. Over 16 million of these individuals suffer frequent tinnitus, and about 2 million experience tinnitus so severe that it interferes with daily living activities. Nationally, the total cost of first-year hearing loss treatment is projected to multiply five-fold between 2002 and 2030, from $8.2 billion to $51.4 billion. These NHANES epidemiological audiometric data will also provide national reference distributions – normative data – that can be used to screen for deficiencies across the U.S. population, and with the oversampling of minorities and other economically-disadvantaged individuals, it provides a barometer for disparities. Most adult-onset hearing losses are permanent. In the U.S., noise exposure is a major cause of preventable hearing loss. Twenty-two million U.S. workers are exposed to noise annually, and 24% of hearing difficulty among workers is attributable to workplace noise exposure. Noise-induced hearing loss (NIHL) is the second most commonly reported occupational disease and the most expensive disability for military and Federal workers’ compensation. In recent years, some factors may have resulted in reduced loud noise exposure, such as better industry compliance with OSHA noise standards, implementation of noise-reducing innovations in the workplace, as well as the continuing shift of jobs away from manufacturing sector in the U.S. economy. Noise does not just occur on-the-job; approximately 21 million adults have acquired a non-occupational NIHL. Sources for non-occupational noise exposure include firearms use and many environmental or recreational exposures to loud music or noise, such as frequent attendance at loud sporting events and working with electrical tools or machinery. As the Nation’s population ages and survival rates for infants and for people with severe injuries and acquired diseases improve, the prevalence of hearing loss and other communication disorders is expected to rise.